Full Research Project 1: Testing the Efficacy of an eHealth Decision Support Tool to Help Latinx Cancer Patients Make Informed Decisions About Tumor Genomic Testing

Project Summary
Full Research Project 1 – Genomic Testing
Testing the Efficacy of an eHealth Decision Support Tool to Help Latinx Cancer Patients Make Informed
Decisions About Tumor Genomic Testing
TU FCCC: Sarah Bauerle Bass, PhD, MPH (Co-Leader) and Michael Hall, MD, MS (Co-Leader)
HC: Tracey A. Revenson, PhD (Co-Leader) and Ana F. Abraído-Lanza, PhD (Latinx Culture Leader)
The use of tumor genomic profiling (TGP) to identify potential cancer treatments can also identify secondary
hereditary risks the patient was unaware of. ASCO policy mandates communication of TGP risks and elicit patient
preferences for managing these types of results. Latinx patients have increased cancer risk and mortality but are
especially vulnerable to barriers that would impede optimal decision making about secondary genetic risks,
including language and acculturation barriers, access and affordability, deportation risks, medical mistrust and low
genetic knowledge. The primary goal of this study is to evaluate the efficacy of an electronic health (eHealth)
decision support tool (DST) to increase informed decision making among Latinx patients. This proposal builds on
current RCT results of testing an eHealth DST called Gene Pilot with Black cancer patients and formative work
with Latinx patients funded by the pilot mechanism of the current U54 Partnership. These studies use innovative
commercial marketing methods to address TGP concerns, promote informed decision making, and increase
communication with providers about preferences for secondary genetic information. Grounded in the Ottawa
Framework, the study will determine the efficacy of a revised DST, Gene PilotLX, compared to traditional decision
support. Specific aims are: 1. Revise the Gene Pilot DST to reflect formative work with Latinx cancer patients to
incorporate specific cultural values and language needs. We will use formative results and establish Community
and Scientific Advisory Boards to revise content to make it culturally-anchored. We will then conduct user testing
with 25 Latinx cancer patients; 2. Test the impact of Gene PilotLX in a randomized trial. We will conduct a fully
powered RCT with 232 Latinx cancer patients at four oncology sites. Intervention participants will have access to
Gene PilotLX via a tablet or personal device; the comparison arm will receive non-targeted education materials
about TGP. Primary outcomes include decision preparedness, decisional conflict, and communication of
preferences with a doctor. Secondary outcomes include communication of preferences with family and changes in
perceptions of TGP. H1: Those in the Gene PilotLX arm will have greater reduced decisional conflict and higher
decision preparedness compared to the non-targeted decision aid. H2: Those in the Gene PilotLX arm will report
communicating TGP preferences with their oncologist more when compared to the non-targeted information arm;
and 3. Determine whether the effects of Gene PilotLX on primary and secondary outcomes are moderated by
Latinx cultural values and acculturation. H3: Gene PilotLX will have a larger effect on primary outcomes for those
holding stronger values of familismo and those who are more acculturated than those with lower values. The
reverse will occur with the Latinx value of fatalismo. Break Systemic Barriers to Inclusion: In line with the U54’s
Inclusive Excellence vision, this study addresses systemic barriers by focusing on Latinx-specific challenges to
engaging and communicating about TGP, thereby reducing potential cancer health disparities by improving
informed decision making in an under-studied population at high risk of cancer.